Mechanism of APBB2 contributions to glaucoma

Abstract Glaucoma is a group of age-related neurodegenerative diseases characterized by loss of retinal ganglion cells and their axons. Because RGCs are post-mitotic neurons, their loss is permanent and causes a gradual decline leading toward irreversible blindness. Unfortunately, glaucoma manifests in a way that damages US society more broadly—it disproportionately affects certain racial groups. Glaucoma is a worse problem amongst African Americans than Caucasians. Though socioeconomic factors often contribute to this disparity, a large part is biological and driven by genomic differences between racial groups. A recent breakthrough points to APBB2 as central to glaucoma in African Americans. A large genome-wide association study (GWAS) has found a single nucleotide polymorphism in APBB2 (rs59892895) with genome-wide significance (P=2x10-8; Odds ratio=1.33), and successfully replicated the finding in additional cohorts. identified a variant in the APBB2 gene as an important cause of glaucoma in people of African descent. ABPP2 encodes a cytoplasmic adaptor protein with multiple protein-protein interaction domains. Remarkably, the high-risk allele is present in approximately 21% of African Americans and apparently absent from Caucasians. Our team has contributed to this discovery of APBB2 as a gene of importance to glaucoma in African Americans, and as additionally shown in our Preliminary Data, have developed a hypothesis that overexpression of APBB2 is the disease-causing mechanism. To test this new hypothesis, we recently generated and now have in hand, a mouse model on a pure C57BL/6J genetic background that is overexpressing Apbb2. The strain was created by the University of Iowa Genome Editing Facility and features a full-length mouse Apbb2 (transcript variant 1) under control of a ubiquitous promotor (CAG) and includes a 6His/3XFlag attached to the N-terminus (abbreviated as B6- Tg(Apbb2). The experiments of this proposal utilize this new strain as a central resource to complete the important, but somewhat high risk, test via manipulation that over-expression of Apbb2 promotes glaucoma. In Specific Aim 1, we propose to test the anatomical and physiological consequences over time of Apbb2 overexpression in mice. This Aim will also complete a thorough characterization of the B6-Tg(Apbb2) strain. Specific Aim 2 will study APBB2 from a molecular perspective, identifying retinal APBB2 binding partners that will guide future mechanistic and candidate-driven genetic experiments.

Public health relevance
PUBLIC HEALTH RELEVANCE: Glaucoma is a common group of age-related neurodegenerative diseases characterized by loss of retinal ganglion cells and their axons that carry information from the eye to the brain. Recent genetic studies in large human populations have identified a genetic variation in the APBB2 gene which increases the likelihood of glaucoma, especially among African Americans. Our proposed experiments will test the function of APBB2 using a recently developed mouse model and ultimately help in the search for improved glaucoma treatments.